University of South Florida Site Consortium - Adolescent Medicine Trials Network for HIV/AIDS Interventions (ATN) Operations and Collaborations Center (UM2 Clinical Trial Optional)

ABSTRACT University of South Florida
The USF Adolescent HIV Consortium will collaborate with the Adolescent Trials Network (ATN) Operations and
Collaborations Center (OCC) by engaging, enrolling, and retaining adolescents and young adults, both at risk
of and living with HIV, in care and research through a well-established clinical and research infrastructure. This
highly reliable, inclusive consortium structure serves southwest Florida and includes community-based
programs, youth representatives, local health departments, health systems and academic institutions. The
consortium will utilize proven strategies and innovative programs to respond to the needs of youth and the
community. Through engagement at the site and individual collaborator level with the ATN Scientific
Leadership Group, the consortium will implement and investigate new research strategies that will result in
improved prevention and treatment of HIV infection and address pressing issues of youth living with HIV. We
will leverage our experience, mature partnerships, and diverse patient population to address priority areas of
the ATN agenda and serve as a model for community empowerment and participation.